Developmental Research Program

PROJECT SUMMARY/ABSTRACT: Developmental Research Program
The overall objective of the Developmental Research Program (DRP) within the Vanderbilt-Ingram Cancer Center (VICC) SPORE in Gastrointestinal (GI) Cancer (hereafter, VICC GI SPORE) is to encourage innovative translational research in GI cancer. The DRP will be led by a Director (Richard Peek, MD) and will be supported by the Developmental Research Advisory Committee (DRAC) comprised of senior investigators at Vanderbilt, Meharry Medical College (MMC), and Tennessee State University (TSU). This alliance allows for identification of talented DRP candidates, and ensuring innovative science. The DRP leadership has significant crossover with the leadership of the Career Enhancement Program (CEP) to encourage CEP recipients to apply for DRP funding and to identify promising investigators from DRP that may qualify for CEP awards. The VICC GI SPORE DRP will use an established and highly effective procedure to solicit applications from investigators at Vanderbilt, MMC, and TSU. Internal and external researchers, including members of the GI SPORE External Advisory Board (EAB), will review applications using the NIH 9-point scoring system. External reviewers will be selected by Dr. Peek and members of the DRAC based on expertise. Reviewers will evaluate scientific merit and the likelihood of the project to support current GI SPORE activities, obtain extramural funding, and/or lead to future GI SPORE projects. The administrative core will solicit the reviews, provide all reviewers the application and score sheet, collect and collate the reviews, and forward these to Dr. Peek and the DRAC for final decisions on support. As described in our rebuttal letter, we will now obtain 3 reviews for each application and have applicants give oral presentations to the DRAC prior to funding decisions. Special emphasis will be placed on attracting early-career investigators into GI cancer research, high-risk/high-gain projects, and projects that apply novel technologies to GI cancer research. Thus, the VICC GI SPORE DRP will offer the opportunity for new directions of study that may be of higher risk but which also have a significant chance for reward, including independent funding and additional projects that may form the basis of the next competing renewal.